PHASE II, DOUBLE-BLIND TRIAL OF RECOMBINANT HUMAN NERVE GROWTH FACTOR IN HIV INF

Neuropathy produces sensory symptoms in up to 30% of patients with advanced HIV infection, producing pain and limiting function. Recently, neuronotrophic factors have been suggested as candidates to treat or prevent a wide range of peripheral and central nervous system disorders.